IGF::OT::IGF : PREPARATION AND DISTRIBUTION OF RESEARCH DRUG PRODUCTS. N01DA-15-7792. PERIOD OF PERFORMANCE 01/15/2015 - 01/14/2020.

The Contractor shall acquire, analyze, store, and ship bulk drugs, other chemical compounds, and drug dosage forms to aid NIDA in promoting drug abuse and drug addiction research.